INSULIN--AN EFFECTOR OF STEROIDOGENESIS IN FEMALES

To examine the effect of hyperinsulinemia on the steroid output from the female ovary. Recent work suggests differences between male and female hormonal responses to high insulin states.